Biomechanical Mechanisms of Benign Paroxysmal Positional Vertigo

Project Summary. Our overall goal is to improve the differential diagnosis and treatment of complex
multi-canal benign paroxysmal positional vertigo (BPPV) and related disorders of the labyrinth. We will
achieve this goal using an array of morphological, computational and experimental methods focused on
semicircular canal biomechanics in health and disease. The project has 5 Specific Aims: Aim 1 will apply
statistical shape modeling and principal component analysis to quantify inter-subject variance in human
membranous labyrinth morphology, which is essential to design of robust canalith repositioning
maneuvers (CRMs). Aim 2 will construct and validate computational and physical models to easily
simulate all forms of BPPV, diagnostic tests, and candidate CRMs across a diverse range of labyrinth
morphologies. Aim 3 will develop and test "universal" CRMs that are robust to morphological variability
and designed to clear all 3 ipisilateral canals of otoconial debris in a single movement sequence. Aim 4
will experimentally evaluate the head impulse tests (HIT) as part of the test battery for differential
diagnosis of canalithiasis, cupulolithiasis, cupuloperfluo and canal jam. Aim 5 will determine if short-arm
posterior canalithiasis and cupulolithiasis can account for type 2 BPPV and characteristics of nystagmus.
We expect results to quantify sensitivity of standard of care CRMs to morphological diversity, determine
if HITs are useful in differential diagnosis of BPPV and related conditions, and introduce a robust universal
CRM.

Public health relevance
Benign paroxysmal positional vertigo (BPPV) is the most common cause of isolated vertigo and is usually caused by dislodged utricular debris that is free to move in the endolymph (canalithiasis) or resting/adhered to the cupula (cupulolithiasis). Although the fundamental origins of BPPV are well understood, the complex patient-specific morphology of the membranous labyrinth, diverse locations/numbers of particles in numerous canals, debris adhesion, and the possibility that the lumen might be partially occluded (canal jam) can make diagnosis and treatment challenging. The proposed work will combine neural recordings in an animal model of BPPV with detailed computational and physical models to improve diagnostics and treatments.